Data Management and Statistics Core

SUMMARY DATA MANAGEMENT AND STATISTICAL CORE
The Data Management and Statistical (DMS) Core aims to provide (1) data management and (2) statistical and
bioinformatic support to research at the Stanford Alzheimer's Disease Research Center (ADRC). The various
ADRC Cores will generate vast amounts of data, including demographic and clinical data from the Clinical
Core, image data from the Imaging Core, genomic and proteomic data from the Biomarker Core, multi-omics
and image data from the Neuropath Core, enrollment data from the Outreach Core, and additional data from
ADRC-supported research projects.
To facilitate relevant research within and beyond the Stanford ADRC and to maximize the value of the
collected data, the DMS Core plans to enhance and expand the current data management system based on
REDCap. These improvements aim to streamline the data collection process, reduce potential errors, and
simplify data sharing. Additionally, the DMS Core plans to develop a web portal to enable convenient data and
resource inquiries, interactive data analysis, and direct data access when authorized.
The statistical and bioinformatic support provided by the DMS Core includes, but is not limited to, study design,
statistical analysis, data mining, software development, and manuscript writing. The Stanford ADRC's focus on
deep phenotyping necessitates intelligent analysis and integration of data from multiple sources to uncover
underlying disease mechanisms. The DMS Core will encourage and support the development of novel
statistical and bioinformatic methodologies specifically tailored for Alzheimer's disease research.
Finally, the DMS Core is dedicated to the education and training of junior researchers, particularly those from
diverse backgrounds and underrepresented groups. DMS Core will also collaborate with Outreach Core and
Clinical Core in designing strategies that maximize the enrollment and retention of under-represented
participants.